Project 3: Role of stromal cell-activated CNOT6L deadenylase in driving AML transformation

Role of stromal cell-activated CNOT6L deadenylase in driving AML transformation.
AML has long been thought to be exclusively driven by genetic or epigenetic mutations within HSCs. Besides
these classical mechanisms, the BM stromal microenvironment plays a crucial role in the pathogenesis,
maintenance and resistance to treatment of malignant clones. Using osteoblast-specific β-catenin models of
AML and MDS, and cells from MDS patients that progressed to AML, we have identified a transcriptional event
that is highly associated with MDS to AML transformation. Compared to MDS, AML cells show increased
expression of the deadenylase CNOT6L. CLOT6L expression is also upregulated in cells from AML versus MDS
patients in several cohorts, and additional mouse models of AML transformation. Overexpression of Cnot6l in
HSPCs of MDS mice induces AML evolution. Cnot6l-induced AML is passaged to secondary healthy recipients
Conversely, CNOT6L inactivation reverses AML transformation. In contrast to AML cells, CNOT6L expression
is downregulated in healthy myeloid progenitors as compared to HSCs of humans and mice and in
megakaryocyte progenitors of subjects with DNMT3AR882 CH. Notably, Cnot6l expression in HSCs is increased
upon chronic IL-1 treatment suggesting that it may also be part of the regenerative response that involves
emergency myelopoiesis (EM) and promotes clonal expansion with inflammation. Thus, maintaining low
CNOT6L mRNA levels may maintain myeloid lineage differentiation whereas increasing it may favor AML
transformation of ARCH or MDS. Indeed, CNOT6L expression is highly associated with AML founder mutations
in the TCGA database and with MDM4 expression. Our hypothesis is that stromal cell amplified CNOT6L-
mediated deadenylation can drive AML development from pre-AML states of MDS and in the context of aging-
related stress factors of ARCH and inflammatory stress in the marrow. We will determine the role of CNOT6L in
AML initiation with aging and age-related loss factors of ARCH and inflammatory stress with EM engagement;
determine how Cnot6l promotes clonal heterogeneity by defining and validating the mutational profile and
transcriptional targets/mechanisms of CNOT6L-related AML evolution using mouse modeling along with single
cell mutational and transcriptional sequencing to define clonal trajectory in mice and primary patient samples;
and, characterize stromal cell mechanisms that induce Cnot6l-dependent MDS to AML transformation using
primary patient samples and mouse models and scRNAseq and spatial mapping. These studies will identify
transcriptional and clonal events driven by the stroma that are significant contributors to AML transformation.
Early transformative events may be therapeutically targeted thus implementing a potentially more effective
therapy that is preventive rather than curative.

Public health relevance
PROJECT 3 NARRATIVE We have identified a stroma cell-triggered transcriptional event driving MDS to AML transformation. We will delineate the mechanism of this pathway in AML evolution and clonal dynamics. These studies will identify transcriptional and clonal events that are significant contributors to AML transformation, define the role of the stroma in their regulation and can lead to new therapeutic approaches that target stroma-elicited signals to prevent or treat AML.